Enhancing Children's Cognitive Function and Achievement through Carotenoid Consumption

Project Abstract
Adequate diet quality has the potential to promote childhood cognitive health and have a lasting impact on
children’s ability for learning and achievement. My laboratory has identified that lutein, a plant pigment or
carotenoid found in rich quantities in dark green vegetables, is uniquely suitable for supporting childhood
cognition and achievement. Lutein is the predominant carotenoid in neural tissue, serving roles as an antioxidant
across neural membranes. Further, lutein, along with two other carotenoids (i.e., zeaxanthin and
mesozeaxanthin) accumulate in the macular as macular pigment, which is known to strongly correlate with brain
lutein. My work has linked macular pigment optical density (MPOD) – a noninvasive measure of retinal and brain
lutein – to greater childhood cognitive function. However, the cognitive implications of lutein and zeaxanthin
intake in children have not been directly investigated. This proposal aims to establish a causal relationship
between lutein intake, cognitive function, and academic performance. The central hypothesis is that lutein
consumption will benefit cognitive function and academic achievement in preadolescents. I also anticipate that
gains in cognitive outcomes will be mediated by the improvement in MPOD. These hypotheses will be tested by
conducting a randomized placebo-controlled double-blind trial to examine the effects of 9-month carotenoid
supplementation on MPOD, cognition (attention and memory), and achievement among 8-10-year-old children
(N=288, 144/group). The active supplement will comprise of 10mg lutein + 2mg zeaxanthin. This work will provide
the evidence-base for recommendations to improve dietary practices for optimal childhood cognitive function
and achievement. The proposed research is relevant to human health and the NIH mission because it will provide
novel data supporting evidence-based recommendations to improve dietary practices for optimal cognitive
function and achievement in childhood.

Public health relevance
Project Narrative The proposed research is relevant to human health because it will provide novel data supporting evidence-based recommendations to improve dietary practices for optimal cognitive function and achievement in childhood. Establishing the evidence base for nutrients that may have neurocognitive implications is particularly important given that the majority of children in the United States perpetually consume diets that fail to achieve their recommended servings of vegetables. Therefore, by furthering our understanding of nutrition for children’s cognitive function, the proposed research is relevant to the NIH mission to improve the health of the nation.